International Council for Harmonisation of Technical Requirements for Pharmaceuticals for Human Use

Geneva, 1 October 2020
Funding Opportunity RFA-FD-21-002
Project Summary
International Council for Harmonisation of
Technical Requirements for Pharmaceuticals for
Human Use
The International Council for Harmonisation of Technical Requirements for
Pharmaceuticals for Human Use (ICH) is an international non-profit organisation the
purpose of which is to promote public health through international harmonisation of
technical requirements that contributes to the timely introduction of new medicines and
continued availability of the approved medicines to patients, to the prevention of
unnecessary duplication of clinical trials in humans, to the development, registration and
manufacturing of safe, effective, and high quality medicines in an efficient and cost-
effective manner, and to the minimisation of the use of animal testing without
compromising safety and effectiveness.
A major output of ICH’s work is the development of harmonised technical guidelines on
Quality, Safety and Efficacy topics. The ICH Guidelines represent agreed-upon scientific
guidance for meeting technical requirements for registration of pharmaceutical products.
Each ICH Regulatory Member is expected to implement ICH Guidelines in line with ICH
Procedures according to its national/regional requirements, with the stage of
implementation of all ICH Guidelines also being dependent on when a Member joined
ICH. Monitoring the progress of international harmonisation and coordinating efforts in
this regard is an important ICH focus. As part of its effort to achieve global harmonised
implementation of ICH Guidelines, ICH is also working on ensuring that high quality
training is available based upon scientific and regulatory principles outlined in the ICH
Guidelines. The ICH Secretariat provides administrative and project management
support for these activities.
To-date 65 harmonised ICH Guidelines on Safety, Quality and Efficacy topics, as well
as Multidisciplinary topics have been developed.

Public health relevance
Geneva, 1 October 2020 Funding Opportunity RFA-FD-21-002 Narrative International Council for Harmonisation of Technical Requirements for Pharmaceuticals for Human Use The International Council for Harmonisation of Technical Requirements for Pharmaceuticals for Human Use (ICH) works to promote public health through international harmonisation of technical requirements that contributes to the timely introduction of new medicines and continued availability of the approved medicines to patients, to the prevention of unnecessary duplication of clinical trials in humans, to the development, registration and manufacturing of safe, effective, and high quality medicines in an efficient and cost-effective manner, and to the minimisation of the use of animal testing without compromising safety and effectiveness.